Progressive acquisition of novel neural crest derivatives along the neural axis during vertebrate evolution

The neural crest is a uniquely vertebrate cell type that is thought to have played an
important role in vertebrate evolution by forming peripheral ganglia and jaws, thus facilitating
predation and expansion of the brain. In the parent grant, we are testing the hypothesis that
there was progressive expansion of neural crest derivatives during the course of vertebrate
evolution. As case in point, lamprey lack a vagal neural crest that in gnathostomes forms the
enteric nervous system. To further understand the evolution of the enteric nervous system in
basal vertebrates, in this supplement we propose to examine the complexity of the lamprey ENS
in comparison to other vertebrates to gain insight into elaboration of the enteric nervous system
in the vertebrate lineage. To explore this, we propose to transcriptionally profile lamprey ENS
both by single cell RNA-seq and spatial transcriptomics to enable comparison with the ENS of
jawed vertebrates. The results promise to elucidate how new cell types arose during vertebrate
evolution under the umbrella of the neural crest.

Public health relevance
Project Narrative In all vertebrate embryos, the neural crest gives rise to the sensory, autonomic and enteric nervous system, craniofacial skeleton and melanocytes of the skin. Not only does the neural crest have the capacity to form an amazing number of embryonic cell types, but also neural crest stem cells persist in adult tissue. Because neural crest cells are involved in a variety of birth defects such as Hirschsprung’s disease, cleft palate and various types of cancers, like melanoma and neuroblastoma, the results of this proposal regarding evolution of neural crest cell differentiative ability will provide important understanding of the normal development of these cells that can later lead to disease states.